High-throughput Modeling of Autism Risk Genes using Zebrafish - DIVERSITY SUPPLEMENT

PROJECT SUMMARY
Autism spectrum disorder (ASD) is caused by both environmental and genetic factors, with the genetic
contribution estimated at 60-80%. Dozens of genes that increase risk for ASD have been identified, most based
on de novo mutations, but these mutations are predicted to account for only 15-20% of ASD cases. Thus, the
majority of the genetic contribution to ASD is predicted to result from common and rare inherited variation, but
few such genes have been identified. Recently, using whole genome sequencing, we reported genome wide
evidence for >60 ASD risk genes, 26 of them novel for ASD, with signals derived from inherited and de novo
protein truncating or missense mutations. The functions of most of these genes are unknown, so a crucial and
necessary next step is to explore their impact on neurodevelopment and neuronal function using a model
organism. The current pace of translating genetic risk factors into phenotypes, mechanisms and therapies is
limited in part by inefficiencies with in vivo mammalian model systems, which makes them impractical for creating
and behaviorally testing large numbers of mutant lines. Here, we leverage the zebrafish, which occupies a niche
as a vertebrate model with features amenable to both in vivo screening and mechanistic understanding, including
a conserved yet small vertebrate brain, behaviors relevant to ASD, and cost-effectiveness relative to mammalian
models. While the zebrafish cannot recapitulate ASD and has limitations for modeling a human disorder, an
emerging literature supports the notion that it is a useful model to study the functions of genes that contribute to
ASD risk. Rather than assess ASD-risk genes one at a time, we will accelerate progress towards mechanistic
understanding via high-throughput assays and analyses. In the parent grant, we proposed to use whole-brain
calcium imaging to study neuronal network properties of zebrafish ASD risk gene mutants at the larval stage of
development. This diversity supplement application describes an experimental and conceptual career
development plan for a graduate student whose experimental goals are to (1) establish a system for brain-wide
calcium imaging of juvenile zebrafish during presentation of virtual social cues, and (2) use this system to identify
neuronal network properties of zebrafish ASD risk gene mutants compared to wild-type controls in response to
social cues. This experimental plan directly relates to the parent grant by characterizing brain states in response
to social cues at the juvenile stage of development, when zebrafish first show social behaviors. These
experiments are separate from, yet synergize with, the experiments described in the parent grant. Together, the
parent grant and diversity supplement have the potential to identify neuronal mechanisms that explain the
behavioral phenotypes observed in zebrafish that contain mutations in ASD risk genes.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) is caused by both environmental and genetic factors, but most of the genes responsible for ASD remain unknown, and the functions of most ASD risk genes that have been identified are poorly understood. We will use zebrafish as a vertebrate model system to study the effects of a large number of recently-identified ASD risk genes on brain development and behavior. These studies will improve our understanding of the functions of these genes, which may ultimately lead to a better understanding of mechanisms that underlie ASD.